Chemistry of Biological Systems

[unreadable] DESCRIPTION (provided by applicant): This renewal proposal describes plans to continue a vigorous chemistry-biology interface (CBI) predoctoral training program that is designed to train scientists in key aspects of fundamental organic and biological chemistry as well as in scientific disciplines at the interface of chemistry and biology. The program, now in its ninth year, further advances the interdisciplinary training of our most motivated and well qualified students by focusing their graduate academic work around a core curriculum in areas spanning both chemical and biological disciplines. Each trainee may carry out his or her doctoral thesis research in one or more of the laboratories of the twenty two faculty trainers affiliated with the following nine participating units: Chemistry and Chemical Biology, Neurobiology and Behavior, Molecular Biology and Genetics, Biomedical Sciences, Chemical and Biomolecular Engineering, Microbiology and Immunology, Plant Pathology, Plant Biology and Nutritional Sciences. [unreadable] [unreadable] All participating faculty have strong research programs either in chemistry with strong biological connections or in biology with strong chemical connections and are well-funded. Their overall research interests are broadly distributed over chemistry (synthetic organic, bioorganic, biophysical, polymer, x-ray crystallography and proteomics) and biology (protein structure and function, enzymology, immunology, signal transduction, chemotaxis, host/pathogen interactions and genetics). CBI trainees attend seminars in their core disciplines (usually weekly) in their respective units, participate together with faculty in a special monthly CBI seminar program, and organize monthly CBI "literature lunches". Two additional features distinguish the Cornell CBI program. First, trainees invite, organize, and host special CBI seminar speakers each semester. Secondly, trainees are required to participate in internships in biotech, life science, or pharmaceutical companies, through which they gain exposure to, and experience in, interdisciplinary biomedical research. [unreadable] [unreadable] [unreadable]